Probing Biomolecular Condensates in Live Cells using Microsecond-scale Single Molecule Rotational Diffusion Microscopy (µs-SiMRoD)

PROJECT SUMMARY
The crowded conditions within cells present a complex physicochemical challenge for maintaining the
solubility and fluidity of thousands of distinct macromolecules. High macromolecular densities promote assembly
into a variety of distinct structures, which in turn can lead to the formation of insoluble solid aggregates. Though
solidified structures could indeed serve protective purposes or as quiescent storage sites, they are more
generally considered to be toxic to the cell. The physical constraints and properties generated by crowded cellular
environments, which contribute significantly to the functional behaviors of the resident molecules, are often
difficult to probe experimentally. In addition to membrane-bound compartments, which define the primary
structural organization of cells, numerous membraneless organelles (MLOs) populate the cytoplasm and the
nucleoplasm providing additional complexity. These biomolecular condensates (BMCs) form via liquid-liquid
phase separation (LLPS), a process that concentrates the resident macromolecules, but which in turn also can
promote additional phase states, including solid aggregates. Multiple BMC-resident proteins that undergo LLPS
in vitro are the dominant proteins in cytoplasmic inclusions found in patients with a range of devastating
neurological disorders. In one such example, the fused in sarcoma (FUS) protein accumulates in MLOs termed
stress granules (SGs), which form as a natural response to various cellular stress conditions. The high molecular
density of FUS in SGs is potentially an essential early step toward the formation of FUS-containing solid
inclusions linked to amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD). Directly observing
the formation and growth of such inclusions within a cellular context is challenged by the lack of appropriate
tools. While genetic approaches to attach fluorescent tags are commonly used to determine spatiotemporal
behaviors, their attachment can often perturb function, there are generally only a few reasonable attachment
points, and such probes have inferior photophysical properties. Recent improvements in genetic code expansion
to incorporate non-canonical amino acids (ncAAs) for in cellulo labeling promises to significantly extend the types
of questions that may be addressed. This is particularly relevant for the application of multiple single molecule
biophysical strategies. The Specific Aim of the proposed work is to identify and characterize solid aggregates
within live cells. To accomplish this, designer MLOs will be used to specifically modify FUS via ncAA-mediated
fluorescent labeling in cells. Microsecond-scale single molecule rotational diffusion (µs-SiMRoD) microscopy will
then be used to probe for local environmental constraints such as increased viscosity or structural confinement.
The target application will be identifying and monitoring solidified FUS-containing aggregates. This strategy is
expected to be instrumental for identifying unknown pathways leading to the formation of solid aggregates, and
thus, it will likely provide new leads into disease onset. The developed methods are expected to be broadly
useful for probing the physical properties of numerous BMCs within cells.

Public health relevance
PROJECT NARRATIVE Solidified aggregates containing proteins that initially phase separate into liquid assemblies are hallmarks of multiple devastating neurological diseases. Novel fluorescence microscopy approaches for characterizing the physical properties of macromolecular assemblies will be applied to identify solid aggregates containing the fused in sarcoma (FUS) protein in live cells. Assessing where such solid aggregates initiate and grow is expected to reveal potential pathways for the onset of amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) at the cellular level.